Assessing Cardiovascular Risks in Deaf Adolescents who use Sign Language

DESCRIPTION (provided by applicant): Scott R. Smith, MD, MPH is a deaf pediatrician who is bilingual in English and American Sign Language (ASL). His career has focused on health care in special and often underserved populations including deaf children and adolescents who use sign language. Dr. Smith's career objective is to become a leading expert and independent researcher to conduct breakthrough research in cardiovascular health knowledge and literacy in deaf adolescents. The University of Rochester provides Dr. Smith with an ideal environment to work towards his objective with Rochester having a large population of deaf children and people and the University of Rochester Medical Center being motivated to become a center of excellence on health promotion and disease prevention with people who are deaf. Dr. Smith will pursue more advanced research training including formal coursework, mentored individualized curricula, consultative supports, mentorial advisory committee meetings, field trips, and national conferences to develop the necessary research skills and community collaborations to achieve his goals and objectives. Furthermore, because deaf people who use ASL appear to be at a higher risk for specific cardiovascular risks including obesity, Dr. Smith will work with his mentors, consultants, and advisors to conduct a research project to further his research skills development and to generate new and valuable information about critical cardiovascular health knowledge and literacy skills of deaf ASL adolescents. They will accomplish this by developing a new written English measure and survey of specific cardiovascular health knowledge and literacy related to diet, exercise, and personal family cardiovascular history based on findings from focus groups and cognitive interviews of deaf adolescents. They will then adapt this written English survey into computer- based English audio and visual and computer-based ASL video surveys and administer these surveys to cohorts of deaf and hearing adolescents to evaluate their specific cardiovascular health knowledge and literacy. Dr. Smith will share the data with the deaf and health care communities to plan future research and interventions to address the cardiovascular health disparities of the deaf ASL community.

Public health relevance
PUBLIC HEALTH RELEVANCE: The overarching aim of this proposed Mentored Career Development Award is for Scott Smith, MD, MPH to become an independent physician-scientist with a career focused on cardiovascular health knowledge and literacy in deaf adolescents who use sign language. The aim of the proposed mentored research project is to assess specific cardiovascular health knowledge and literacy skills in deaf adolescents who primarily communicate through American Sign Language (ASL) by developing a new measure and survey of critical cardiovascular health knowledge and literacy skills focused on diet, exercise, and personal family history. We will focus this new measure to capture aspects of health literacy not yet measured in literature, which will lead to more effective interventions to address and reduce the critical cardiovascular health disparities in the community of deaf people who communicate through sign language. (End of Abstract) PROJECT NARRATIVE The overarching aim of this proposed Mentored Career Development Award is for Scott Smith, MD, MPH to become an independent physician-scientist with a career focused on cardiovascular health knowledge and literacy in deaf adolescents who use sign language. The aim of the proposed mentored research project is to assess specific cardiovascular health knowledge and literacy skills in deaf adolescents who primarily communicate through American Sign Language (ASL) by developing a new measure and survey of critical cardiovascular health knowledge and literacy skills focused on diet, exercise, and personal family history. We will focus this new measure to capture aspects of health literacy not yet measured in literature, which will lead to more effective interventions to address and reduce the critical cardiovascular health disparities in the community of deaf people who communicate through sign language. __SpecificAimsTextDelimiter__ SPECIFIC AIMS AND HYPOTHESES The overarching aim of this proposal is to assess the cardiovascular health knowledge and literacy skills of deaf adolescents who use sign language. We will accomplish this objective by developing and piloting a new ASL-based measure of health knowledge and literacy skills focusing on specific cardiovascular topics including diet, exercise, and personal family cardiovascular history. This will be the first measure of specific cardiovascular health knowledge and literacy skills that focuses on deaf ASL adolescents such as their informal and incidental knowledge as well as their interactive health literacy and critical health literacy skills. Little research has been conducted to evaluate and address specific health knowledge factors and health literacy skills among deaf Americans of any age. Few studies have addressed deaf people's difficulties accessing informal and incidental information, interacting with others to obtain new information, and evaluating different types of information. As a result, the aims of this proposal are both exploratory and hypothesis-driven. Technical Aim 1: To recruit two cohorts of 6 to 12 deaf ASL high school students aged 14-18 from different educational backgrounds Technical Aim 2: Focusing on diet, exercise, and personal family cardiovascular history, to develop specific cardiovascular health knowledge and health literacy assessment tools appropriate for hearing and deaf ASL adolescents Technical Aim 3: To recruit an appropriate sample of deaf ASL adolescents aged 14-18 from different educational backgrounds to participate in the ASL cardiovascular health knowledge and literacy survey Technical Aim 4: To recruit a comparative sample of hearing adolescents aged 14-18 from different educational backgrounds to participate in the English cardiovascular health knowledge and literacy survey Research Aim: To study specific cardiovascular health knowledge and health literacy skills of deaf ASL adolescents Research Question 1: What are the gaps in deaf ASL adolescents' knowledge about specific cardiovascular health information? Hypothesis 1: Deaf ASL adolescents will demonstrate significant gaps in their knowledge about diet, exercise, and personal family cardiovascular history when compared to hearing adolescents Research Question 2: What are the barriers that deaf ASL adolescents face in obtaining further specific cardiovascular health information? Hypothesis 2: Deaf ASL adolescents will report many more specific barriers interfering with their ability to obtain further information about diet, exercise, and personal family cardiovascular history when compared to hearing adolescents Research Question 3: What are the obstacles that deaf ASL adolescents face in developing their skills to evaluate different types of specific cardiovascular health information? Hypothesis 3: Deaf ASL adolescents will describe many more specific obstacles interfering with their ability to evaluate different types of information about diet, exercise, and personal family cardiovascular history Findings of this research will be used to generate specific hypotheses and provide further information to aid the design and implementation of health educational intervention programs for deaf ASL adolescents and potentially for other populations. Studying the effectiveness of these intervention programs would logically follow this Career Development Award.